Targeting Gbg-GRK2 signaling in fibrotic remodeling

? DESCRIPTION (provided by applicant): Heart failure (HF) is a devastating disease with poor prognosis. Pathologic cardiac remodeling is characterized by progressive hypertrophy, apoptosis and fibrosis. Fibrosis exacerbates cardiac remodeling, arrhythmias, sudden cardiac death, and decreased ventricular compliance; emerging evidence suggests that cardiac fibroblasts (CFs) play a key role in these processes. To date, there are no therapies that target fibrosis. Elucidating the role(s) of CF in pathologic remodeling may hold substantial therapeutic potential. CF studies have been limited by the lack of genetic reagents in vivo. We are collaboratively characterizing two novel mouse models (PeriostinMerCreMer and Tcf21MerCreMer knock-in mice) that permit targeted and inducible manipulation of CF function/viability to directly determine the mechanistic basis of cardiac fibrosis. Chronic G- protein coupled receptor (GPCR) stimulation in HF elicits pathologic upregulation of GPCR kinase 2 (GRK2) that is recruited to membrane Gβγ subunits to desensitize agonist-occupied GPCRs. We and others have demonstrated therapeutic potential for inhibiting Gβγ-GRK2 interaction in HF. Our novel, small molecule Gβγ- GRK2 inhibitor, gallein, attenuates pathologic cardiac remodeling, normalizes GPCR signaling and reduces interstitial myocardial fibrosis in HF. To explore a fibroblast-restricted role for GRK2 in myocardial fibrosis, GRK2fl/fl mice have been bred with POSTNMerCreMer and Tcf-21MerCreMer. Our exciting preliminary data suggest that the GRK2fl/fl-POSTNMerCreMer mice are significantly protected following cardiac ischemia/reperfusion (I/R) injury, with no further protection conferred by gallein. Interestingly, GRK2fl/fl-POSTNMerCreMer mice appeared to be more protective than GRK2fl/fl-αMHCMerCreMer, suggesting that greater cardioprotection may be provided via the CF than previously thought. Worsening renal function and fibrosis often accompanies HF progression; it is a strong predictor of mortality in advanced HF patients (cardio-renal syndrome 2, CRS2) but remains poorly understood. TAC or I/R injury resulted in substantial kidney fibrosis and dysfunction in our studies; systemic gallein attenuated CRS2 as well as renal dysfunction and fibrosis following acute renal I/R injury. Our hypothesis is that Gβγ-GRK2 plays an important role in pathologic CF activation in HF progression and kidney dysfunction and that its inhibition holds therapeutic promise for HF and CRS2. To address our hypothesis, we propose the following Aims: Aim 1: Determine the therapeutic efficacy and specificity of Gβγ-GRK2 inhibition or GRK2 ablation in a clinically-relevant HF model in wild type and inducible CF or CM GRK2-/- mice (+/- Gallein). Aim 2: Elucidate the cellular mechanisms underlying Gβγ-GRK2 inhibition in fibroblasts and validate Gβγ-GRK2 inhibition as a therapeutic target in both mouse and human cardiac fibrosis and HF. Aim 3: Determine the role of Gβγ-GRK2 signaling in renal fibrosis and CRS2. We believe this proposal, with Gβγ-GRK2 inhibitory compounds, validated in CF-restricted GRK2-/- mice, holds therapeutic promise for HF. The principle may also extend to CRS2 and other fibrotic diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE: Heart failure, the final manifestation of most cardiovascular disease, is a devastating disease with poor prognosis that remains a leading cause of mortality in the United States. The underlying molecular mechanisms of cardiac remodeling and dysfunction in heart failure are not fully understood. This proposal aims to better understand the molecular and cellular bases of heart failure and its accompanying renal dysfunction, which may lead to the identification of novel therapeutic targets and strategies for treating heart failure.